EFFICACY AND SAFETY OF MIBEFRADIL IN HYPERTENSION VERSUS LOSARTAN

The objective of the current study is to evaluate the differnce between mibefradil and losartan in the change of mean trough sitting diastolic blood pressure (SDBP) measurements after 8 weeks of active treatment. This study includes a 4-week placebo run-in period followed by an 8-week treatment period. During the first 4 weeks of the treatment period, the patients receive either mibefadil (50mg), or losartan(50mg). At week 4, patients responding to the study drug, mean trough SDBP<90mmHg, will continue on the same study drug at the same dose for four more weeks. Patients with mean trough SDBP>90mm Hg, will titrate up to a final dose of 100 mg once daily for the remaining 4 weeks through weeek 8.